Examining the Role of Nono Pathway on the Innate Immunity Against Oncolytic Adenoviruses

PROJECT SUMMARY / ABSTRACT
Recent clinical trials in adults and children with brain tumors from our group and others have shown that
oncolytic viruses prolong the survival of a small percentage of patients (<20%). Importantly, these studies have
also demonstrated that viroimmunotherapy induces Tcell infiltration into brain tumors. Such findings support
the paradigm-shifting concept that complete tumor debulking by virotherapy requires the elicitation of antitumor
immune responses following the initial oncolytic effect. Therefore, further enhancement of the immune arm of
this treatment approach may be required to increase the percentage of positive responders. In a clinical trial
developed by the MDACC team, 20% of GBM patients treated with the oncolytic adenovirus Delta-24-RGD
showed complete response and survival longer than three years (NCT00805376). Although these studies have
illustrated that robust immune responses can be invoked using oncolytic virotherapy, they have also shown
that viruses are eliminated early during infection and thus preventing the development of an efficacious anti-
tumor immune response in the majority of the patients. The first mechanism that is activated to eliminate the
virus is the innate immune response. Mitigation of this response should result in the permanence of more
viruses and during a longer period within the infected tumor, increasing the window of opportunity for the
development of an anti-tumor immune response. During a screening of the factors regulating the anti-
adenovirus innate immune response using RNA sequencing, we discovered that the NONO pathway, which
was not previously connected with adenovirus infection, was significantly upregulated following infection.
Based on this seminal information, we hypothesize that NONO pathway is an essential sensor of adenovirus
DNA and capsid proteins in infected cells and that plays a key role in the modulation of an effective innate
immune response against oncolytic viruses. To test this hypothesis and achieve the objectives of the project,
we proposed the following two specific aims: Specific aim 1: To examine the NONO pathway in glioma
cells treated with oncolytic adenoviruses. We hypothesize that NONO functions as a viral capsid sensor in
response to adenoviral infection and interacts with players of the host’s innate immune response. Specific aim
2: To determine the immunomodulatory functions of NONO during oncolytic adenovirus treatment. We
hypothesize that evading innate immune defenses allows for enhanced adenovirus replication and lysis,
functionally tipping the scale towards anti-cancer immunity. Therefore, we will test the therapeutic efficacy of
Delta-24-RGD oncolytic, as well as monitor the flux of cancer-specific T-cells and innate immune activation in
the context of differential NONO expression. If successful, our project should propel the exploration of viral
capsid-based recognition and NONO-cGAS crosstalk in the design of new oncolytic adenovirus strategies.
This project is part of our long-term goal of legitimizing oncolytic adenoviruses as part of the conventional
treatment for malignant gliomas and other solid tumors.

Public health relevance
PROJECT NARRATIVE Oncolytic viruses constitute a distinct type of cancer immunotherapy. Here we aim to investigate a newly discovered mechanism involving innate immune sensing of adenoviral capsid proteins by the NONO pathway. These data should open new avenues for the development of more potent oncolytic adenoviruses capable of inducing more robust and sustained tumor lysis than current therapeutic agents.